This service is for Micro-contract for DMPK Expert services for BPN, HEAL and Biologics. - HEAL

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.